Center for Circadian Rhythms and Alcohol-Induced Tissue Damage

ABSTRACT
Only a subset of individuals with an alcohol-use disorder develop clinically significant organ damage (~10-
30%) but it is not known what factors predispose individuals to develop clinically significant organ pathology?
There is compelling evidence to support the hypothesis that disruption of circadian homeostasis (e.g., shift
work, social jet lag) is a plausible susceptibility factor for vulnerability to alcohol-induced pathologies. Interest in
the study of circadian rhythms is growing; however, an obstacle to study the interactions between circadian
rhythms and alcohol-induced organ damage has been the lack of a combined circadian rhythm and alcohol
expertise that is required to conduct these studies as well as the high cost associated with establishing the
infrastructure necessary to perform circadian research. The objective of this R24 Alcohol Research Resource
Program is to overcome these obstacles by providing the necessary infrastructure, support, and expertise that
will allow both alcohol researchers in the United States and internationally to incorporate the study of circadian
rhythms into their existing research programs. In order to achieve this objective we propose the following
Specific Aims: Aim 1. Provide the essential resources to conduct novel, innovative studies involving alcohol
and circadian rhythms. The proposed infrastructure, expertise and personnel in our R24 Program will allow
alcohol researchers to investigate innovative hypotheses by conducting studies in our facility. At the conclusion
of each study, investigators will be provided with biospecimens from their study to evaluate study-specific
outcomes. Aim 2. To provide biospecimens from alcohol-fed, circadian disrupted mice and circadian disrupted
humans consuming alcohol. Our R24 Alcohol Research Resource Program will provide biospecimens (from
our biorepository) to alcohol researchers to investigate hypotheses using standardized experimental
manipulations and assessments. The biospecimens will be from studies that have already been conducted and
those that are available for request including both human and mouse specimens. Aim 3. Provide consultation
and analytic tools for circadian rhythm research. Our R24 Alcohol Research Resource Program will be a
resource for the alcohol research community by providing consultation and training in circadian rhythms
research (Aim 3a) and by conducting circadian-specific analyses of data collected in other laboratories (Aim
3b). The resources of this NIAAA R24 Alcohol Research Resource Program will facilitate scientific rigor and
reproducibility across labs in alcohol and circadian rhythm experimentation. These efforts are expected to lead
to a significantly greater understanding of the overlapping or dissimilar disease mechanisms in each organ
which should lead to identification of novel targets and interventions to prevent and treat alcohol-induced organ
damage.

Public health relevance
NARRATIVE The COVID-19 pandemic has transformed and threatens our society. However we know very little about the underlying mechanisms and comorbidities that cause severe symptoms in some COVID-19 patients. Alcohol use has been shown to make the flu and other respiratory diseases worse and we think this may be true for COVID-19 and alcohol as well. This study will investigate if alcohol use makes COVID-19 worse and how. Identifying this new information about COVID-19 pathology and a role for alcohol could support new recommendations from physicians regarding alcohol and new targets for COVID-19 patient therapies.